Identifying Optimal, Translatable Tobacco Cessation Interention Components

Use continuationpagesas needed to provide the required information in the format shown below. Start withProgram Director(s)/PrincipalInvestigator(s).List all other senior/key personnelin alphabetical order, last namefirst. Name eRA Commons User Name Organization Role on